Social epigenetics of Alzheimer's disease and related dementias in Latin American countries

PROJECT SUMMARY (ABSTRACT)
Alzheimer’s disease (AD) and related dementias like frontotemporal dementia (FTD) disproportionately affect
Latinos and socioeconomically disadvantaged groups. Nevertheless, the bulk of the research exploring the
multifaceted biology of dementia, which includes both genetic and epigenetic aspects, has predominantly been
focused on Caucasian populations and higher-income countries (HICs). To address these disparities and expand
dementia research in Latin America countries (LAC) and low-income countries, our group has established the
NIH-NIA/Tau Consortium/Alzheimer Association funded Multi-Partner Consortium to Expand Dementia
Research in Latin America (ReDLat) cohort study of Latinos with AD, FTD, and healthy controls. ReDLat
represents a first-in-class dataset of Latinos with AD, FTD, and demographically matched healthy controls
consisting of biospecimen collection, standardized clinical, neuropsychological, genomic, neuroimaging, and
SDH data, which our research group has utilized to identify unique combinations of environmental and genetic
factors of dementia in Latin American Countries (LAC). Our preliminary epigenetic data reveals shared and
distinct epigenetic DNA methylation differences related to AD and FTD, including a "Hispanic Paradox" with
epigenetic biomarkers underestimating biological aging in Latinos despite AD and FTD diagnoses. Moreover,
our preliminary data harnessing matched SDH data from ReDLat suggests a link between altered DNAm states
of inflammatory, stress, and cardiometabolic genes and socioeconomic status. Our overall hypothesis is that
a social adversity-epigenetic signature in immune cells at regulatory regions of proinflammatory, stress, and
cardiometabolic genes associates with dementia presentation and heterogeneity in Latinos. In this proposal, we
test this overall hypothesis and add epigenetic DNAm data to the ReDLat cohort by (1) leveraging existing blood
biospecimens from 1,600 participants (n=400 AD, n=400 FTD, n=800 controls) with different social determinants
of health (SDH) levels, including a low-middle income country (Colombia), an upper middle-income country
(Argentina), and HICs countries (Chile and the US) and (2) leverage existing ongoing rolling ReDLat recruitment
to add an out-of-sample validation epigenetic dataset of 400 additional participants (n=100 AD, n=100 FTD, and
n=200 controls) to generate an epigenetic dataset from 2,000 total Latinos in ReDLat. With these rich epigenetic
data, we will identify shared and distinguishing epigenetic DNAm features associated with AD and FTD
presentation in Latinos. Moreover, we will utilize this extensive epigenetic dataset to better understand the
interactions between specific SDH factors and distinct epigenetic changes in the genome. Understanding
dementia presentation through the lens of epigenetics and SDH in Latinos across diverse regions of LAC and
the US will advance regionally-informed novel strategies to address dementia disparities by paving the way for
targeted interventions and prevention strategies that take into account both epigenetic and SDH factors.

Public health relevance
PROJECT NARRATIVE This proposal will study the interplay between epigenetics of immune cells and social determinants of health in Latinos with Alzheimer's disease and frontotemporal lobe dementia from an established NIH funded Multi- Partner Consortium to Expand Dementia Research in Latin America (ReDLaT) cohort. This project aims to both compare and contrast molecular changes within immune cells of diverse people's genes associated with Alzheimer's disease and frontotemporal lobe dementia and links to social determinants of health. This project addresses the lack of diversity in epigenetic studies of Alzheimer's diseases and related dementias and advances efforts towards global strategies of addressing dementia disparities.